Impact of a Novel Community-Based Biobehavioral Chronic Pain Team Training Program (4PCP) on Practitioner and Patient Outcomes

Impact of a Novel Community-Based Biobehavioral Chronic Pain
Team Training Program (4PCP) on Practitioner and Patient Outcomes
ABSTRACT
Although primary care medical practitioners (PCPs) provide the first and sometimes only line of
treatment for patients with chronic pain, surveys show they are generally not comfortable with its
management. This may reflect a dual shortcoming in their educational preparation. First the average medical
school spends 0 to 6 hours on chronic pain, when pain organizations like the International Association for the
Study of Pain (IASP) suggest 74 hours. Second, medical training is primarily oriented towards a
biopharmacologic framework. While drugs may help the nociceptive component of pain, and anxiety or
depression, they offer little to address the core emotional, cognitive and behavioral roots of chronic pain. This
biopharmacologic mindset, that a drug might “do it all”, may have set a stage for today's opioid crisis.
Managing these deeper chronic pain issues requires a biopsychosocial framework, that views a chronic
pain syndrome as a brain disorder, reinforced by years of negative cognitive, emotional and behavioral habits,
requiring retraining through physical & behavioral activation, and cognitive restructuring. However, since this
framework and skillset are foreign to most PCPs, they remain ill-prepared to manage the totality of a chronic
pain syndrome. In the 4PCP (Primary Practice Physician Program for Chronic Pain) pilot, we demonstrated
that PCPs eagerly learned and implemented this new framework into their practice, increasing confidence with
chronic pain management, reducing visit times, and improving patient pain. That study did not formally
address opioids, though physicians tapered opioids spontaneously.
We now ask 2 new questions: (1) Will a dissemination-ready, fully codified, intensive version of 4PCP
produce better outcomes, sustained for 2 years? (2) Will practitioners find new confidence and skills in
managing pain as a team and taper opioids? In 27 practices (4 practitioners each, 108 total) in 4 cities
(Bozeman, Cleveland, Madison, Milwaukee) we will teach the new curriculum, 3 practices at a time every 2
months over 18 months, using a stepped cluster design. Practices will co-train with a paired psychologist and
PT to build a clinical team. For each practitioner, we will identify 10 patients with chronic pain, ideally on
opioids (1080 total) for patient outcomes. We will measure 3 types of outcomes before and for 2 years after the
training intervention: (1) patient improvement; (2) the change in practitioner satisfaction with care rendered
and practitioner burnout; (3) the change in opioid prescribing in the enrolled patients based on state records.

Public health relevance
PROJECT NARRATIVE Drugs may help the sensory part of chronic pain and the anxiety and depression that follow, but they do not address its core emotional, cognitive and behavioral roots, which require a biobehavioral approach, typically foreign to most primary care practitioners (PCPs). Our prior work showed that PCPs skillfully appropriate and implement this approach with 4PCP, a training program for PCP's to manage chronic pain effectively, resulting in greater work satisfaction and improved patient outcomes. Here we propose to train 27 practices in 4 cities using an intensive, codified and dissemination-ready version of the training and measure whether over the ensuing 2 years: (1) patients have less pain and (2) PCP's are happier with their work, and (3) fewer opioids are prescribed.